Molecular Mechanisms of Human Homologous Recombination

SUMMARY/ABSTRACT
Organisms are constantly exposed to environmental conditions that challenge the integrity of the genome.
Loss of genomic integrity contributes to the development of most cancers. DNA double strand breaks (DSBs)
are a dangerous type of DNA damage that can lead to rapid loss of sequence information stored within the
genome. Homologous recombination (HR) is one of the primary DSB repair pathways and is predicated on
locating an undamaged DNA sequence that matches the damaged DNA sequence elsewhere in the genome.
The homologous sequence can then be used to restore the lost DNA sequence information. During normal
mitotic growth, HR preferentially repairs DSBs using sequence information stored in the sister chromatid.
Aiding in maintenance of allelic variation between genes and preventing unbalanced exchange of genetic
information between chromosomes. In contrast during meiosis the homologous chromosome becomes the
preferred DNA repair substrate. There is a large amount information on existing pathways that have evolved in
S. cerevisiae to promote DNA repair from the homologous chromosome during meiosis. However, little is
known about how homologous chromosomes are used for repair in humans. One of the key determinants in
chromosome choice during HR, is the organization of the presynaptic complex (PSC). The regulation,
formation, and activity of the human PSC is controlled by >45 proteins. However, a basic functional unit of the
PSC consists of RAD51 and associated factors (RAD54L) during mitosis, and RAD51, DMC1 and their
associated factors (RAD54L, RAD54B, HOP2-MND1) during meiosis. Understanding how these proteins
organize into active complexes during HR is a critical step in understanding how human homologous
chromosomes are used for HR. Over the course of our studies we will use biochemical and single molecule
approaches to understand the mechanism behind RAD51 and DMC1 self-segregation during meiotic PSC
formation. We will understand how DMC1 forms a meiotic homology search complex, and with cooperation of
accessory proteins, aligns DNA sequences. We will identify how meiotic homology search complexes
overcome chromatin. Finally, we will work to understand how conflicts between the two highly related motor
protein RAD54L and RAD54B may promote homologous chromosome use during human mitotic HR. In
summary, the primary goal of this research proposal will be to use molecular biology, biochemistry, and single
molecule approaches to understand how human mitotic and meiotic PSCs organize, and promote DNA
sequence alignment during HR. The data we collect from these experiments will be used to build a model for
how human homologous chromosome selection may occur during both mitotic and meiotic HR.

Public health relevance
PROJECT NARRATIVE This program seeks to understand how human enzymes prevent the loss of genomic integrity. We will learn how organization of key homologous recombination intermediates promote DNA sequence alignment, and chromosome template choice.